The role of sialylation in glia-neuron communications and stress responses

The project focuses on the molecular, cellular, and genetic mechanisms underlying the neural functions of
glycoprotein sialylation. Although the brain is the organ with the most prominent sialylation in human body, and
recent studies implicated sialylation defects in several neurological diseases, the functions of this important type
of glycosylation in the nervous system are still poorly understood. The intricacies of glycosylation, increased
pleiotropy and redundancy, and limitations of available genetic approaches significantly hinder the research on
sialylation in the overwhelmingly complex vertebrate nervous system. A suitable model system would be an
important tool for more efficient mechanistic studies in this area. The proposal focuses on Drosophila as a model
organism to investigate the neural functions of N-linked sialylation. Several key evolutionarily conserved
enzymes were previously characterized in the Drosophila sialylation pathway, including DSiaT, a sole
sialyltransferase in Drosophila, and CSAS, CMP-Sialic Acid Synthetase producing sugar donor for DSiaT. Using
a combination of in vitro and in vivo approaches, previous studies revealed that Drosophila sialylation is highly
regulated process limited to the nervous system and involved in control of neural excitability, development of
neuromuscular junctions (NMJs), and the regulation of voltage-gated channels. Novel functions of N-linked
sialylation in the nervous system regulation suggested by previous research are expected to be conserved in
humans and be relevant for pathologic mechanisms of neurological diseases. Preliminary research revealed that
sialylation is involved in glia-neuron interactions, and that defects of sialylation result in neurodegeneration and
increased sensitivity to oxidative stress. CSAS was found to be responsible for rate-limiting effect on Drosophila
sialylation, playing a key role in neural regulation. The proposed project will capitalize on previous and preliminary
data to extend research towards (i) revealing sialylation-mediated mechanisms of glia-neuron coupling, (ii)
elucidating the role of sialylation in promoting neuronal viability and resistance to oxidative stress, (iii)
characterizing functional and molecular targets of sialylation using advanced chemical biology and
glycoproteomics approaches. The research plan is based on interdisciplinary strategy that combines the
advantages of Drosophila model, including amenability to genetic manipulations, exhaustively characterized
nervous system, low redundancy of glycosylation pathways, and well-established neurobiological methods, with
advanced biochemical and glycoproteomic approaches. The results will shed light on conserved principles of
neural regulation and homeostasis, which will be valuable for biomedical feilds. Moreover, the project will
establish Drosophila as a versatile model for future research on glycosylation in the nervous system to uncover
pathological mechanisms of neurological diseases.

Public health relevance
Glycosylation modifies protein functions and profoundly affects the development and physiology of human brain. We will use Drosophila as an experimentally amenable, genetically tractable and well-studied model organism to elucidate functions of glycosylation in the nervous system. Our research will shed light on mechanisms of brain development and suggest novel therapeutic strategies for neurological disorders associated with abnormal excitability and neurodegeneration.